BCCMA: Cardiovascular Remodeling following Arteriovenous Fistula Creation: Autophagy Contributes to Adverse Arteriovenous Fistula Remodeling

Project Summary/Abstract
The arteriovenous fistula (AVF) is the lifeline for Veterans with end-stage kidney disease (ESKD)
requiring hemodialysis therapy. Arteriovenous fistulas (AVF) are the preferred vascular access for
hemodialysis patients with end stage kidney disease. A large proportion of AVFs (30-60%) created in the
United States fail to successfully mature. The high failure rates after AVF creation reflect our poor
understanding of the mechanisms leading to AVF maturation failure; and the lack of therapies to prevent or
treat this problem represents an unmet clinical need. Our Collaborative Merit Award (CMA) is an integrated
and synergistic proposal assembling a group of VA investigators focused on improving AVF maturation failure
for Veteran hemodialysis patients. The Overall Research Strategy is to elucidate mechanisms of AVF
maturation failure in order to develop novel therapies to mitigate this unmet clinical need. The overall rationale
for this CMA is that fibrotic venous remodeling influences intimal hyperplasia development and successful
outward remodeling, and mitigating these biological problems could improve successful AVF maturation.
Specifically, the CMA will define those mechanisms by which aging (Project 1), Type VIII collagen in smooth
muscle cells (Project 2), and endothelial cell autophagy (Project 3) determines venous remodeling after AVF
anastomosis. The overarching hypothesis of this CMA project is that the biology of AVF maturation is
influenced by mechanisms regulating venous fibrotic remodeling. Specific to project 3, we will investigate the
role of endothelial cell (EC) autophagy in fibrotic venous remodeling in AVF maturation. The mechanisms
leading to AVF maturation failure are poorly understood; and the lack of therapies to treat this clinical problem
in hemodialysis patients represents an unmet clinical need. Our central hypothesis is that impaired endothelial
cell autophagy, after AVF creation, promotes venous fibrotic remodeling, leading to AVF maturation failure. We
will address our central hypothesis with three specific aims: Specific Aim I: Demonstrate the role of EC
autophagy in the setting of disturbed flow and its impact on profibrotic signaling, Specific Aim II: Demonstrate
the role of EC autophagy in venous fibrosis and AVF remodeling, and Specific Aim III: Demonstrate the
association of EC autophagy with venous fibrosis and AVF maturation.

Public health relevance
Project Narrative Arteriovenous fistula (AVF) maturation failure remains the preferred vascular access for hemodialysis patients in the United States. The mechanisms of AVF maturation failure remains poorly understood. Project 3 evaluates mechanisms of how autophagy regulates fibrotic venous remodeling in the AVF vein after AVF creation. The proposed research is relevant to Veterans’ health because it will help improve the understanding of why AVFs fail to mature after creation and lead to development and testing of effective novel therapies to treat this important clinical problem in Veterans’ patients with end stage kidney disease requiring hemodialysis therapy.